Administration Core

CORE A : The overall mission of the Organization and Administrative Core (Core A) is to provide oversight, coordination, decision making and leadership needs required to meet the scientific, administrative and fiscal objectives of this POl Program Grant. The Specific Aims of this Core are as follows: Specific Aims: 1. Provide fiscal management and oversight for the Program. 2. Provide administrative support including manuscript preparation, meeting planning and organization to promote integration of all Projects and Cores to facilitate progress and efficient use of resources. 3. Provide data management, information service support and lab management support to promote organization, sharing and dissemination of research data and reagents. 4. Foster communication and collaboration between participants and other Centers including the University of Michigan Comprehensive Cancer Center (UMCCC). 5. Help facilitate translation of promising discoveries/technologies through our Office of Technology Transfer and academic-industry relationships. RELEVANCE (See instructions): Overall, the Administrative Core will be used to ensure the integration, function and productivity of all aspects of the Program.